A Digital Health Technology to Prevent Family Violence and Improve Child Mental Health

7. Project Summary/Abstract
The COVID-19 pandemic has increased the need for eHealth interventions that target families and children at-
risk of family violence and long-term mental health problems. Escalating rates of anxiety and depression during
COVID-19 have impacted families adversely, and have led to impaired parent-child relationships and increased
family conflict (Russell et al., 2020). These risks are exacerbated by increases in mental health problems and
limited access to social support and treatment (Taylor et al., 2021). The challenges of parenting coupled with
increases in stress and violence during COVID-19 have accelerated the need for treatments that target these
problems. Furthermore, the COVID-19 pandemic has widened the gap between families who have services
and support and those who do not, increasing health disparities in this population. As such, we have developed
the Family Check-Up Online to support families and children by improving family relationships and mental
health. The FCU Online has the potential to reduce health disparities by providing an accessible, easily
disseminated version of the FCU to families at-risk of adverse outcomes after COVID-19. A recent and timely
systematic review of telehealth therapy for families suggest that they are equally effective as in-person
treatments, and improve both parent mental health and child outcomes (McClean et al., 2021), supporting the
use of eHealth approaches for mental health intervention. In the proposed application, we will examine the
feasibility and commercial potential of the FCU Online by interviewing key stakeholders in schools and school-
based mental health settings. We propose to improve the back-end structure of the FCU Online, which was
previously developed as part of a clinical trial, to support wide-scale commercialization of the product including
flexible module delivery, progress monitoring, and self-enrollment. We will test the product with a series of
stakeholder focus groups and usability testing to evaluate the feasibility and acceptability of the product for
commercialization. In Phase II, we plan to develop and test e-learning models for coach training as well as
evaluate the product in a clinical trial to examine the reach, effectiveness, adoption, implementation, and
maintenance of the program in real-world settings. Our team includes experts in implementation and
dissemination, evidence-based interventions for at-risk families, business development and marketing, and
product development. Letters of support from community and school providers demonstrate our strong
partnerships that will facilitate this research. The study will significantly contribute to our understanding of
mobile ehealth interventions for students at-risk of violence in school settings.

Public health relevance
8. Project Narrative Violent behavior in the home and the mental health problems that result from violence adversely impact long- term health outcomes for children and adolescents. This application focuses on examining the feasibility and commercial potential of a mobile, web-based application for children and families in order to reduce digital inequalities in treatment delivery in this population and improve long-term mental health. By interviewing school providers, improving the back-end structure, and conducting usability testing, we plan to evaluate the commercial-ready version of the product in order to promote wide-scale dissemination of this evidence-based treatment to schools.